CORE--SCIENTIFIC

The Scientific Core is intended to serve as a central resource for using MRI and Anatomical/Pathological techniques to support Projects 1 (Moskowitz), 2 (Bonventre), 3 (Finklestein). This Core will be directed by Drs. Bruce Rosen and Bradley Hyman.